Core C-Data Management & Statistics Core

Core C: Data Management and Statistical Core
Project Summary/Abstract
Efficient, clean, and organized data, together with valid, flexible, and reproducible statistical design and
analysis techniques, are an integral component to achieving the scientific mission of the UCI ADRC: to
discover, quantify, and validate factors that influence the risk of AD across the lifespan. The overarching goal
of the Data Management and Statistical Core (DMSC) is to provide logistical and intellectual support to all
ADRC investigators at all phases of scientific projects. Data management support includes comprehensive
data management and dissemination of data arising from the Uniform Data Set (UDS) and all ADRC projects.
DMSC personnel are responsible for the development of National Alzheimer's Coordinating Center (NACC)
approved collection forms, maintenance of the ADRC database, and the timely transfer of accurate data to the
NACC. DMSC faculty and staff will also be intimately involved in the conception, design, implementation,
analysis, and reporting of research conducted by members of the ADRC. The DMSC emphasizes regular
communication with ADRC investigators and proactive involvement in ADRC-sponsored projects. The DMSC
also promotes the development of independent research programs among its members. During the proposed
research period, projects will include the development and validation of novel data collection mechanisms for
harmonizing heterogenous Big Data streams, as well as the development of novel statistical methodology for
efficient biomarker discovery and validation. These DMSC-specific research endeavors will increase the
intellectual contribution of the DMSC to the scientific community at large, and will also lead to improved
methods for collecting, entering, and analyzing complex data obtained through local ADRC projects.
!